Elucidating Novel Cyclic Nucleotide Signaling Pathways and Physiological Effects in Bacteria

PROJECT SUMMARY / ABSTRACT
Bacteria utilize numerous sensing and signaling pathways to alter behaviors that allow host colonization of both
bacterial infections and microbiomes. Bacteria translate changes in the extracellular environmental into
intracellular signals, such as nucleotide-based signaling molecules, to rapidly respond and optimize physiology
for survival. Understanding these signaling pathways is necessary to be able to predict bacterial behavior under
different conditions and to rationally develop new methods to alter medically relevant bacterial phenotypes.
Recently, we have identified roles for atypical nucleotide signals, 2’,3’-cyclic nucleotide monophosphates (2’,3’-
cNMPs), in controlling transcription, translation, biofilm formation, and stress resistance in E. coli and Salmonella
enterica. This research program will elucidate the molecular mechanisms that control 2’,3’-cNMP-dependent
effects, the intersection with paradigmatic nucleotide-based signaling pathways, and the broad physiological
effects of 2’,3’-cNMP signaling. To do so, we will synthesize chemical tools and use a variety of in vitro and in
cellulo techniques to interrogate the effects of 2’,3’-cNMPs in bacterial transcription, translation, signaling
pathways, and phenotypes in E. coli. In addition, we will use biochemical and genetic assays to identify metabolic
enzymes and binding partners. Results from E. coli will be extended into other bacterial species to understand
the conservation and diversity of 2’,3’-cNMP signaling, as well as determine the potential for targeting 2’,3’-cNMP
pathways for development of new antibiotics. Ultimately, this program will provide novel insights into the cellular
roles of 2’,3’-cNMP signaling in bacteria, as well as develop (bio)chemical tools and fundamental knowledge that
can be applied to investigate 2’,3’-cNMP signaling in other organisms.

Public health relevance
Project Narrative This program will elucidate the molecular interactions governing a novel nucleotide signaling pathway that modulates key phenotypes important in bacterial infection and microbiome colonization. We also will investigate the intersection(s) with other cellular signaling pathways and identify metabolic enzymes, which will allow us to predict the physiological effects of the nucleotide signaling pathway in diverse species. These efforts will enable the pursuit of the novel nucleotide signaling pathway as a potential target for antibiotics, as these signaling molecules control key medically relevant phenotypes, including biofilm formation, stress responses, and growth.